Project 1: Mediators of Lung Adenocarcinoma Metastatis

Project 1 (Massagué): Mediators of lung adenocarcinoma metastasis
PROJECT SUMMARY
Our goal in this project is to elucidate the molecular and cellular determinants of lung adenocarcinoma
(adenoCa) metastasis, in order to improve the prevention and treatment of lung cancer relapse. Nearly half of
early-diagnosed (stage I and II) lung adenocarcinoma cases develop local and distant relapse despite surgical
resection of the primary tumor. Although cancer cell entry into the circulation and extravasation into distant
organs are important early steps in the metastatic cascade, the predominant concern in the clinic is about
preventing and treating relapse that is driven by cancer cells that were disseminated since before diagnosis.
Therefore, our focus is on metastatic colonization, including the phases of metastatic seeding, latency,
and outbreak. Building on our previous and new mouse models of brain and multi-organ metastasis, in the
current grant period we have identified mediators of metastatic latency and immune evasion by metastatic
stem-like cells (MetSCs) (Malladi et al Cell 2016), and mediators of relapse by residual disease after erlotinib
and crizotinib treatment of lung adenoCa (Obenauf et al Nature 2015). We also identified serpin mediators of
lung MetSC survival in the brain, and defined L1CAM as a mediator of vascular cooption for metastatic
outgrowth (Valiente et al Cell 2014). Moreover, we found that carcinoma-astrocyte gap junctions promote brain
metastasis by cGAS-STING pathway transfer and pharmacologic modulation of gap junctions is effective
against established brain lesions in these models (Chen et al Nature 2016). Our work translated into two
clinical trials, one with gap junction modulator meclofenamate and the other anti-TNF antibody certolizumab,
in patients with stage IV lung adenoCa. Our future Aim 1 is to define and target the role of L1CAM signaling
in lung adenoCa metastasis. We will determine the origin of L1CAM+ lung adenoCa MetSCs, the role of
L1CAM signaling in outgrowth, and how to target L1CAM for inhibition of metastasis initiation and propagation.
Aim 2 is to elucidate the signaling dynamics and immune evasive state of micrometastatic disease.
We will investigate the role of three key pathways –WNT, TGF-β and Hippo– during MetSCs entry and exit
from latency, and the role of NK and CD8+ T cells in enforcing latency by NKG2D-mediated recognition of
ULBP ligands in MetSCs; the ultimate goal is to trigger immune-mediated clearance of residual disease. Our
Aim 3 is to functionally define our recently identified mediators of CNS metastasis as therapeutic
targets. We will characterize connexin 43, complement factor 3, and lipocalin 2 as mediators of brain and
leptomeningeal metastasis, and will pre-clinically test pharmacologic inhibitors of these targets in combination
with therapeutic approaches being developed by other members of this Program Project. Through this work we
hope to contribute innovative ideas for the prevention and treatment of lung cancer relapse while retaining our
long-term focus on discovering basic principles of metastasis.

Public health relevance
PROJECT NARRATIVE The overall goal of this project is to define the molecular and cellular basis for lung cancer metastasis. Cancer cell migration from primary tumor into blood and lymphatics, survival in the circulation, and extravasation into distant organs are important early steps in the metastatic cascade. However, in cancer patients these events have occurred continuously for month before cancer was diagnosed. Therefore, the focus of this project is on metastatic colonization. This project builds on advances during the past grant period in order to now discover and therapeutically target the molecules that allow the seeding of various organs with metastasis-initiating cells, the survival of these cells as latent seed that evade immune surveillance, and their eventual outbreak into overt, aggressive metastasis. These insights will be translated into new approaches for the prevention and treatment of metastatic lung cancer.